A Single Comprehensive Assay for Gene Regulatory Profiling Optimized for Minimal Sample Input Requirements

PROJECT SUMMARY / ABSTRACT
The gene regulatory program of a cell reflects and largely determines cell state, and is a tightly regulated and
dynamic system. In the immune system, rapid changes in gene regulation are required during immune
responses, and also during specification and differentiation of different immune cell types. Indeed, many of the
most important regulatory proteins in immune cells are transcription factors, which specify the regulatory state
of a cell. Multiple genomic assays assess diverse aspects of gene regulation, and represent an important tool
set for modern biology research and biomedicine. Currently, multiple different genomic assays with distinct
readouts are often used in combination to generate comprehensive cell gene regulatory profiles, with a resulting
increase in cost, time, technical expertise and sample requirements. Here we propose to develop a single
multimodal assay optimized for low sample input, which will generate comprehensive gene regulatory information
traditionally only possible using multiple parallel assays. We will optimize the micro-PRO-seq (μPRO-seq) assay,
a next-generation sequencing methodology, which will generate three distinct genome-wide readouts: (i) a
comprehensive and quantitative measure of gene synthesis, achieved by detecting nascent RNA molecules; (ii)
quantitative detection genome-wide of active enhancers, the regulatory elements in the genome that specify
gene synthesis by binding transcription factors; and, (iii) identification of all genes existing in a poised state,
representing a novel mode of gene regulation that positions genes to respond rapidly to activation. This
combination of data has broad applicability, with particular utility for dynamic cell types such as primary immune
cells. By detecting only newly synthesized nascent RNAs, μPRO-seq generates a more accurate snapshot of
actively expressed genes than other technologies – a readout that better reflects response to stimulus or change
in differentiation state. A major goal of modern immunology research, with increasing clinical relevance, is the
identification of the specific transcription factors responsible for immune responses and differentiation across
myriad different immune cell types. μPRO-seq is highly responsive to this demand, in that it directly identifies
active enhancers, which together with the established sequence binding motifs for most transcription factors,
thereby efficiently identifies candidate transcription factors that regulate genes central to immunologic cell fate.
The main objectives of this proposal are to (i) develop and optimize μPRO-seq as a sample-sparing assay, (ii)
establish the utility of μPRO-seq using a panel of different human T cell subsets isolated from male and females
across a range of ages, and (iii) develop informatics tools to maximize the utility of μPRO-seq data for
immunology research and clinical diagnostics. Accomplishing our aims will produce a robust, multimodal,
sample-sparing assay with multiple genome-wide readouts, which in combination produce an unparalleled and
comprehensive delineation of immunologic gene regulatory status.

Public health relevance
PROJECT NARRATIVE This project will develop microPRO-seq (μPRO-seq), which will use only a minimum number of cells to generate a comprehensive multidimensional readout for gene regulation in human immune cells. The new streamlined μPRO-seq assay will quantify both actively expressed genes as well as active enhancers; our sample-sparing method will be an unparalleled tool for both researchers and clinicians in improving gene- targeted research, diagnosis and therapies in humans.